CLINICAL TRIAL OF GROWTH HORMONE IN POST POLIOMYELITIS

The objective of this protocol is to measure the effect of six months treatment with human growth hormone at a physiologic dose on the muscle strength and endurance and on the functional capabilities of subjects with post poliomyelitis syndrome.